Pathogenesis of Respiratory Viruses

DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Pathogenesis of Respiratory Viruses, organized by Adolfo Garcia-Sastre and Peter J.M. Openshaw. The meeting will be held in Keystone, Colorado from January 19 - 24, 2014. Respiratory viruses are a major cause of infectious disease and death in humans. The Keystone Symposia meeting on Pathogenesis of Respiratory Viruses will discuss some of the latest advances in our understanding of the biology and pathogenesis of this group of viruses, including major human pathogens such as influenza viruses, respiratory syncytial virus, parainfluenza virus, rhinoviruses, coronaviruses and adenoviruses. There will be a special emphasis on influenza and respiratory syncytial virus. This meeting will bring together experts in virology, viral pathogenesis and viral immunity to discuss factors contributing to viral replicatio, tropism, disease and immunity in the respiratory tract. Opportunities for synergistic interactions will be significantly enhanced by the concurrent meeting on Innate Immunity to Viral Infections, resulting in a more integrated view of viral disease and immunity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Pathogenesis of respiratory virus infections results from a combination of factors, including virus-specific factors, predisposing conditions, innate and adaptive immunity, and environmental factors. The Keystone Symposia meeting on Pathogenesis of Respiratory Viruses will bring together virologists, immunologists, and pulmonologists, to share and discuss data with a view to extending our understanding of respiratory virus pathogenesis. This understanding is essential for the rational design of needed therapeutics and vaccines against respiratory viruses.